Microfluidic immunoassay as a polysubstance oral fluid screening tool for law enforcement to rapidly identify recent drug use in traffic stops to reduce traffic fatalities and injuries.

Abstract
More Americans are driving under the influence of drugs (DUID) than ever before, leading to an increase in fatal motor
vehicle accidents. With more than 12 million drivers DUID each year, only a fraction of law enforcement officers (8%) has
the advanced training needed to recognize drug impairment in roadside traffic stops, representing about 220 drivers DUID
for every patrol officer with advanced training. Like the breathalyzer for alcohol, presumptive drug screening technology
can aid patrol officers in making standardized and objective decisions for DUID arrest. However, current drug screening
tests are primarily based on immunochromatographic test strips, and, as a result, yield merely qualitative results with poor
diagnostic performance and offer limited drug test menus that are missing high-priority drugs like fentanyl. There is an
unmet need for drug screening technology with performance characteristics like laboratory tests and the ability to measure
multiple high-priority drugs, including fentanyl. Toward this goal, Portable Diagnostic Systems is developing a next-
generation microfluidics-based drug screening tool called the Integrity-1 Analysis System. The Integrity-1 Analysis System
detects low abundance targets in small volumes (<20 𝜇L) of oral fluid with high accuracy and precision, made possible by
the novel microfluidic circulation of fluids over the sensors. When fully developed, the system will feature best-in-class
portability, unparalleled multiplexing capability for more comprehensive drug screening, and analytical characteristics
closer to laboratory-based instrumentation. Our primary objective for this Phase I program is to establish the feasibility of
the Integrity-1 Analysis System for use in drug screening applications. First, we will develop the infrastructure for drug
testing, which involves fabricating test cartridges and reader prototypes to complete the project’s Aims. We will then
develop a multiplexed assay of multiple drugs and/or drug metabolites of high interest to DUID enforcement as well as
clinical toxicology applications, including fentanyl. This work will culminate in a cross-sectional diagnostic accuracy study
of 100 subjects from a population with a high prevalence of drug use. The analysis will compare the diagnostic performance
(sensitivity and specificity) of the Integrity-1 relative to a commercially available oral fluid ICS test, verified by LC-MS as
the reference method. The results of this study will advance our technology toward the goal of developing an initial product
for law enforcement under FDA regulatory discretion, and towards future regulated (510[k] clearance) IVD products in
clinical toxicology and related applications. Our technology, when adopted for DUID enforcement, could help prevent
motor vehicle-related injuries and fatalities, which is consistent with CDC’s high-level strategic goals to protect America
from health, safety, and security threats. While not all persons DUID have substance use disorders (SUD), increasing the
yield of DUID convictions could also lead to earlier intervention for individuals at risk of SUD through addiction treatment
in the drug court system. In addition, near real-time data, facilitated by this technology, could act as surveillance systems to
monitor national trends regarding the population incidence rate of DUID and the types/classes of drugs encountered.

Public health relevance
Narrative We propose to validate a novel microfluidic technology for screening multiple drugs, including fentanyl, in oral fluids with an initial product targeting roadside drug screening by law enforcement to rapidly identify drivers that are under the influence of drugs. This technology addresses an unmet need in a $324M US market (>$1B global market) that can be reached through existing distribution channels and direct sales. Our team is experienced in FDA-regulated in vitro diagnostics product development and capital management with deep insights gained from conducting over 200 customer interviews.